Measuring the functional heterogeneity of endothelial cells in engineered vasculature

Project Summary
Measuring the functional heterogeneity of endothelial cells in engineered vasculature
Clinical translation of tissue engineered products requires the development of vascularized constructs, as most
cells are metabolically dependent on oxygen and nutrient delivery from blood vessels. Current approaches for
establishing engineered blood vessels rely on the ability of endothelial cells to self-assemble into vessel networks
in biomaterial scaffolds. In vivo, endothelial cells are highly heterogeneous, exhibiting varying ability to form
hierarchal vessel structures (i.e., from highly branched, small diameter capillary vessels to larger diameter
arteries/veins). State-of-the-art methods for engineering vasculature overlook this cellular heterogeneity when
combining tissue-derived endothelial cells with scaffolds, resulting in the formation of defective and disorganized
vessel structures that do not efficiently deliver oxygen and nutrients to cells. Thus, there is a critical need to
measure endothelial cell heterogeneity for successful engineering of functional vasculature. Motivated by our
previous work demonstrating that single-cell heterogeneities in mesenchymal stromal cells can be quantified by
specific integrin expression, we propose to measure endothelial cell heterogeneity based on the expression of
integrins and cadherins with various biosensing approaches. Our central hypothesis is that measuring the
expression of endothelial cell surface integrin and cadherin receptors will identify quantifiable
heterogeneities in endothelial cells, which will yield novel approaches to sort heterogeneous endothelial
cell subpopulations and genetically modify the cells’ integrin and cadherin expression to better control
blood vessel formation. We will evaluate cell heterogeneities as the ability of the cells to form blood vessels of
varying diameter, length, and branching index. Our preliminary study correlates the magnitude of β1-integrin and
VE-cadherin expression by primary endothelial cells with vascularization capacity in collagen gels. We will further
quantify the expression of other integrins and cadherins and characterize the ability of endothelial cells to form
various blood vessel geometries in collagen gels (Aim 1). We will then engineer blood vessels with different
geometries using endothelial cells sorted based on integrin and cadherin expression (Aim 2). Finally, we will
genetically modify the expression of integrins and cadherins on endothelial cells both in vitro and in vivo to
regulate their vascularization capacity (Aim 3). Successful completion of this project will yield innovative
approaches to measure, understand, exploit, and manipulate heterogeneities in endothelial cell capacity to self-
assemble into vasculature. Ultimately, these findings will provide a powerful, new approach to precisely control
blood vessel formation and will enhance the clinical success of engineered blood vessel therapies. Furthermore,
this proposal and the opportunities afforded by the COBRE will develop synergistic collaborations to measure
and sense cellular heterogeneities in vascular tissue engineered constructs.

Public health relevance
PROJECT NARRATIVE Project Narrative is not required in this component